Research Program - Molecular Oncology

ABSTRACT
The Georgetown Lombardi Comprehensive Cancer Center (LCCC) Molecular Oncology Program (MO)
brings together investigators whose mission is to identify and validate molecular pathways critical to the
initiation, progression, maintenance and metastases of cancer. The overall goals of MO are to understand
and develop biomarkers for the complex processes of cancer susceptibility, initiation and progression, plus
identify novel targets and novel and repurposed anti-cancer agents that show promise because of reduced
toxicity against normal cells. To accomplish this mission and goals, MO members perform research under
two 2 aims: 1) Define and exploit unique genomic and epigenomic events that initiate and sustain cancer
growth and 2) determine the biological mechanisms that underlie stem cell-like phenotypes, altered
metabolism and the metastatic spread of cancer cells. A significant advances that reflects progress in Aim 1
by Yi found that Yap modulates the immunosuppressive environment in pancreatic ductal adenocarcinoma
(PDAC). For Aim 2, Chung identified theaphenon E treatment significantly decreased γ-OHPdG levels in the
liver DNA of Xpa-/- mice that reduced HCC incidence in these mice to 14% from 100% in the controls. The
LCCC Consortium is comprised of Georgetown Lombardi Comprehensive Cancer Center, based in
Washington, DC (LCCC-DC) and the John Theurer Cancer Center of Hackensack Meridian Health, based
in Hackensack, NJ (LCCC-NJ). Accordingly, the LCCC catchment area is defined by the LCCC-DC and
LCCC0NJ catchment areas. Led by Jeffrey Toretsky, MD and Benjamin Tycko, MD, PhD, the program
has 21 members and 23 associate members from 13 departments across LCCC Consortium institutions. In
the current year, MO members are supported by $7.68M ($7.3M LCCC-DC, $385,226 LCCC-NJ) in
research grant funding (annual direct costs) of which $2.3M ($1.92M LCCC-DC, $385,226 LCCC-NJ) is
peer reviewed and $1.251M (at LCCC-DC) is funded by the National Cancer Institute (NCI). MO is home to
four multi-investigator grants. Productivity is demonstrated by 214 cancer-related publications, 23 of which
were in journals with an impact factor ≥ 8. Cancer and program-related publications included 23% inter-
programmatic, 22% intra-programmatic, 11% inter- and intra-programmatic and 36% that involved
collaborations with another cancer center. MO members collaborate with members of the other three LCCC
Research Programs (Breast Cancer Program [BC], Cancer Prevention and Control Program [CPC], and
Experimental Therapeutics Program [ET]) and use all nine Shared Resources. To support integrated
thematic research, MO houses significant novel technical expertise, including conditionally reprogrammed
cells (CRCs), Zevatars, and a BiaCore 4000.